AIDS CLINICAL STUDIES GROUP

AIDS CLINICAL STUDIES GROUP INCLUDES: AIDS Research Treatment Program Effects of Anti-HIV-Therapy on HIV Load and on HIV-Medicated Modulation of Host Cell Gene Expression and Related Cytopathogenic Progress. Studies on the Specificity and Regulation of Anti-HIV Antibodies Using Human Monoclonal Antibody Technology. The Role and Characterization of Circulating Complexes in Patients with AIDS.